Fostering Institutional Resources for Science Transformation: The FLORIDA-FIRST Health-Science Brigade

PROJECT SUMMARY
Not applicable for this administrative supplement

Public health relevance
PROJECT NARRATIVE Not applicable for this administrative supplement